CORE--RESEARCH TECHNOLOGY DEVELOPMENT

Component 3. Research Technology Activities. Develop a comprehensive system of tools to gather, process, and organize psychological data for analysis. Create a user's manual for the system. Pilot the system in-house and at other centers. Apply system to archive existing OSLC datasets. Key staff. M. Eddy, R. Fetrow